The role of H3K27me2 in regulating Culex pipiens diapause

PROJECT SUMMARY
Insects go through various evolutionary processes to survive in extreme environments
and climates. Diapause is one of the most effective means that many insects adapted for
a temperate environment. Our objective is to determine whether H3K27me2 regulates
diapause traits including extended lifespan, fat accumulation, and enhanced stress
resistance in the northern house mosquito, Cx. pipiens. We have three specific goals for
this project: 1) To establish the link between diapause-relevant genes and H3K27me2
loss in fat body tissues. We will identify the genetic targets of the H3K27me2 and
evaluate the genes’ putative roles in diapause traits using three functional assays: ChIP-
seq, RNA-seq, and RNA interference (RNAi). 2) To identify and characterize the genes
that are activated by H3K27me2 loss to generate the overwintering fat storage and
consumption. We will identify dozens of specific types of lipids in the fat body cells
during the overwintering periods using SSNMR and FTIR methods. Second, we will use
KEGG Mapper to predict higher-level biochemical and functional pathways that are
differentially expressed in fat body tissues exposed to the diapause-inducing condition.
3) To define the roles of the histone demethylase (UTX) and the histone
methyltransferases (E(z) and ESC) in regulating H3K27me2 in order to understand the
mechanisms that extend the lifespan of diapausing mosquitoes. We will characterize the
role of utx, e(z) and esc in modulating H3K27 methylation and lifespan of diapausing
females of Cx. pipiens. This will be achieved by knocking down the expression of these
genes or by injecting chemical inhibitors that target the encoded proteins. We will
monitor the impact on the H3K27 methylation levels and on the survival rates of the
treated Cx. pipiens. Histone methylation is potentially a powerful target for breaking or
reversing diapause-associated physiological changes. Like other epigenetic
modifications, histone methylation is reversible, and thus by altering the activity of the
enzyme that regulates these modifications, it may be possible to develop a novel control
strategy to delay or prevent the onset of overwintering diapause in these mosquitoes
and thus cause significant population loss during the winter season.

Public health relevance
PROJECT NARRAIVE Diapause is a crucial survival strategy in insects for coping with adverse environments and plays a significant role in the spread of vector-borne diseases. The proposed work will provide the precise mechanism of how H3K27me2 induces or suppresses genetic targets, and, subsequently, provide researchers with genetic control of the diapause phenotypes in Cx. pipiens. We anticipate that this work will yield an understanding of how mosquitoes regulate their diapause energetics and aging process, as well as identification of potential targets that could be manipulated and exploited for controlling mosquito populations during their vulnerable overwintering cycle.